Developing and Testing a Trauma-Informed Exercise Intervention for Women Veterans with histories of Sexual Violence

Project Summary
Women Veterans (WVs) disproportionately experience sexual violence (SV) throughout their lifetime. These
experiences of SV are often repeated, resulting in a lifelong pattern of SV victimization which can have
profound negative impacts on physical, mental, and psychosocial functioning and quality of life. Current VHA
policies highlight the need for integrative interventions which effectively address the diverse negative health
sequalae associated with lifetime SV. Yet, there is currently a gap in treatment offerings that address broad
psychiatric, physical, and psychosocial health impacts of SV. Exercise has been shown to improve trauma-
related mental health conditions among survivors of SV and improve trauma-related multimorbidity among
Veterans with a PTSD diagnosis. Yet, many barriers exist to exercise among WVs which contribute to low
exercise engagement from this group. This Career Development Award (CDA-2) thus aims to develop and test
a trauma-informed telehealth exercise intervention tailored for WVs with histories of SV. Treatment
development will be guided by 1) previous interventions completed among Veterans with PTSD, 2)
documented preferences among women with histories of SV, and 3) trauma-informed approaches and
integration of stakeholder feedback. During phase one of this project, we will conduct pre-implementation
stakeholder interviews with 10 WVs with histories of SV and 10 healthcare providers to provide guidance on
the structure and content of the proposed intervention. This information will be used to create the program
manual for the proposed intervention. During phase two of this project, forty WVs aged 21-65 with lifetime
history of SV will be recruited from VISN1 to participate in an open trial consisting of a 12-week, online physical
activity program including aerobic and strength training. Qualitative data will be collected in parallel with
quantitative outcomes to assesses the primary feasibility and acceptability outcomes. Exploratory outcomes
will include functional status. Candidate outcomes to be assessed include physical performance, physical
activity level, PTSD, anxiety, depression, psychosocial function, pain, fatigue, health status, quality of life, and
exercise motivation. This pilot trail will extend our understanding for trauma-informed exercise approaches for
WVs with histories of SV and of the feasibility, acceptability, and potential benefits of exercise for this group.
Results will be used to develop a fully powered randomized controlled trial for WVs with histories of SV. Dr.
Pebole’s training plan will facilitate completion of all research aims and the development of new skills (e.g.,
treatment development and testing, implementation science and processes, advanced qualitative and
quantitative analytic techniques) and professional development to facilitate her research career to
independence. She will participate in didactic and professional development activities throughout the award
period to support achievement of these training goals and receive mentorship from a team of experts in
rehabilitation-focused intervention for Veterans, sexual and interpersonal violence, exercise, and functioning
(Drs. Catherine Fortier, Katherine Iverson, Katherine Hall).

Public health relevance
Exposure to sexual violence disproportionally impacts women Veterans and can have profound negative impacts on daily functioning. Current treatments for sexual violence focus on psychiatric symptoms and ignore frequently co-occurring physical and psychosocial concerns. Exercise can improve trauma-related physical, mental, and psychosocial health conditions and may help women who have experienced sexual violence. Yet, women Veterans experience many barriers to participating in exercise and prefer interventions that are tailored to their preferences. This proposal will develop and test an exercise intervention tailored specifically to women Veterans who have experienced sexual violence. The treatment will be informed by women Veterans with histories of sexual violence and their providers. Feasibility and acceptability will be tested, and outcomes will be explored to inform future research. This intervention is urgently needed to address gaps in integrative care and persistent trauma-related health concerns among women Veterans with histories of sexual violence.